Veteran-Centered Transformation of Pulmonary Hypertension Organization into a Regional Model of Care in VA (TRANSPHORM-VA)

Background: VA is tasked with providing timely, high-quality specialty care for nearly 3 million Veterans, yet
faces unique challenges in doing so, including a large rural Veteran population and specialty provider
shortages. These challenges are particularly evident for pulmonary hypertension (PH), a devastating and
prevalent disease among Veterans with a median survival of only 3.9 years. Patients with PH require frequent
access to PH experts and careful coordination across multidisciplinary teams and facilities to ensure high-
quality care. Yet, VA has not taken a coordinated approach to PH care, and as a result there are wide gaps in
PH care access and quality across VA. The redesign of VA PH care into a hub-and-spoke model is a guideline-
recommended, evidence-based solution to improve PH care quality. The integration of telehealth technologies
into this model, a “telehealth-enhanced hub-and-spoke model,” can advance this model to ensure every
Veteran has equal access to state-of-the-art PH care. Yet, before this innovative solution can be implemented,
several critical research and implementation questions must be addressed, including how to adapt other hub-
and-spoke models to unique PH challenges, and which model components are key to improve outcomes. To
address these knowledge gaps, this proposal will leverage survey data paired with in-depth qualitative
analyses to understand provider and organizational characteristics of high-quality PH care within potential hub
sites. This knowledge will inform the co-design of an implementation blueprint with stakeholder input that will
be used to pilot test the telehealth-enhanced hub-and-spoke model in VISN 1.
Significance/Impact: This research has the potential to improve the organization, access, quality, equity, and
coordination of care for the more than 250,000 Veterans living with PH. Furthermore, by developing a process
to design a telehealth-enhanced hub-and-spoke model that is driven by scientific hypotheses, grounded in
theory, and integrates key stakeholder perspectives, this work will provide VA with key guidance to redesign
specialty care for other specialty conditions.
Innovation: The union of telehealth technologies with the organizational redesign of PH care into hub and
spoke sites represents an innovative model of excellence for PH care to comprehensively address current
gaps in PH care delivery across VA. Additionally, the integration of co-design with health services research and
implementation science to develop a scalable solution to PH care delivery is an innovative approach that will
ensure the solution is relevant and acceptable to key stakeholder groups while being rigorously evaluated for
effectiveness and broader application to other complex redesign and implementation questions.
Specific Aims: Aim 1: Characterize stakeholder perspectives on PH hub site care delivery through mixed
methods. Aim 2: Co-design a blueprint for the reorganization of PH care into a telehealth-enhanced hub-and-
spoke model. Aim 3: Assess feasibility and acceptability of core components of the hub-and-spoke model.
Methodology: In Aim 1a, I will conduct a survey of Veterans and providers within the 22 VA sites that have
existing PH expert clinics (potential future hub sites) to identify provider and organizational characteristics of
high-quality care. In Aim 1b, I will conduct qualitative interviews of Veterans, providers, and clinical leaders at
these potential hub sites to explore their perspectives on current VA PH care and the redesign of care into a
hub-and-spoke model. In Aim 2, I will partner with stakeholders to co-design an implementation blueprint that
comprehensively describes 1) the components of a telehealth-enhanced hub-and-spoke model, 2) evaluation
metrics, and 3) implementation strategies. In Aim 3, I will use the implementation blueprint to pilot test the
model across 2 VISN 1 sites and will assess its feasibility and acceptability.
Next Steps/Implementation: This work will lead to the submission of two IIR proposals, including a hybrid
implementation-effectiveness stepped wedge study across all 8 VISN 1 sites.

Public health relevance
Transforming specialty care for pulmonary hypertension (PH) across VA into a telehealth-enhanced hub-and- spoke model is an evidence-based, guideline-recommended solution to address current gaps in the access, quality, and equity of PH care for the more than 250,000 Veterans living with this devastating disease. Yet, before VA can undertake organizational redesign efforts, a formative evaluation is required to ensure that these efforts will meet Veteran needs and improve Veteran outcomes. Within this study, we will leverage mixed methods data including survey data and qualitative interviews to characterize stakeholder perspectives on PH care within potential hub sites. We will then partner with stakeholders to co-design an implementation blueprint, which will use to pilot test the telehealth-enhanced hub-and-spoke model across two VISN 1 sites to assess the feasibility and acceptability of the model. The results of this work will inform the scaling of the model across all VISN 1 sites in the next phase to assess its impact on clinical outcomes.